The Impact of Public Reporting on Procedural Outcomes Following Congenital Heart Surgery

PROJECT SUMMARY/ABSTRACT
Natalie Jayaram, MD MSB is an Assistant Professor of Pediatrics at the University of Missouri-Kansas
City and a faculty member in the Department of Pediatrics and Division of Cardiology at Children’s Mercy
Hospital in Kansas City, Missouri. As a pediatric cardiologist and health services researcher, her long-term
career goals are to improve the care of pediatric patients with congenital heart disease (CHD) by contributing
to the science of quality assessment, by examining the effectiveness of policy-based initiatives on care, and by
partnering directly with patients to facilitate changes in care. The goal of the current project is to study public
reporting for congenital heart surgery (CHS). Public reporting is designed to provide healthcare consumers
with outcome data for a given provider or institution. Proponents of public reporting advocate for transparent
disclosure of health outcomes data and contend that public reporting results in improved outcomes.1-4 Critics of
public reporting cite evidence that public reporting may not substantially improve outcomes and could result in
unintended consequences, including risk avoidance practices.5-14 Formal study regarding the impact of public
reporting on outcomes for CHS has never been performed. The highly specialized nature of CHD care, with
relatively less local or regional competition compared to more prevalent conditions (e.g. adult cardiovascular
disease) but with patients willing to travel to seek the ‘best’ care,15 suggest that public reporting for CHS
warrants independent investigation. The primary aims of the proposed project are: 1) to evaluate whether, as
an unintended consequence of public reporting, there is a shift in patient case mix, suggesting that centers
could be avoiding surgical intervention in patients at highest risk for poor outcome 2) to evaluate the
association between implementation of public reporting for CHS and surgical outcomes, and 3) to better
understand the type and format of data that CHD patients and families would find most meaningful to help
them make informed decisions regarding care. Study aims 1 and 2 of the project propose obtaining data from
the State Inpatient Database in order to study the association between public reporting, institutional case mix,
and surgical outcomes at centers throughout the US performing CHS. Study Aim 3 proposes focus groups
involving CHD patients and caregivers to gain an improved understanding of their preferences with regards to
public reporting. Together with her mentorship team, Dr. Jayaram has worked to create a career development
plan that will provide her with additional training, education, and experience in the areas of advanced statistical
methodology, experience in working with administrative data, and formal training in qualitative research and
patient engagement. Overall, the skills learned from this project and educational plan coupled with an
outstanding mentorship team will allow Dr. Jayaram to achieve her ultimate goal of becoming an independent
investigator and leader in the field of pediatric cardiovascular outcomes research.

Public health relevance
PROJECT NARRATIVE Only recently has nationwide voluntary public reporting for congenital heart surgery been implemented. The impact of this initiative on outcomes and assessment of caregiver preferences regarding public reporting have not been studied. Given the importance of this data for parents, policy makers, and healthcare providers, an improved understanding of the impact of public reporting on outcomes of patients with congenital heart disease in need of cardiac surgery is needed.